Mechanisms of Intermittent Fasting and Longevity in C. elegans

ABSTRACT
Manipulating evolutionarily conserved mechanisms of nutrient signaling and energy metabolism
promotes healthy aging in many species. While the most robust and well-studied model is dietary restriction
(DR), a chronic reduction in caloric intake without malnutrition, its therapeutic potential is limited by negative
associated side effects and difficulty of clinical implementation. The search to generate more viable therapies
from this research has uncovered alternative dietary interventions that could promote healthy aging, independent
of reduced overall caloric intake. One such regimen is intermittent fasting (IF), which suggests that simply altering
the timing of food intake can increase longevity and disease resistance, independent of caloric intake. These
mechanisms are relatively understudied, but evidence suggests that IF modulates longevity in mechanisms that
are distinct from those of chronic DR. Studying IF-longevity could therefore elucidate novel approaches to target
aging, and IF as a therapy itself may be more translatable than chronic DR. The central aim of this proposal is
therefore to utilize the genetically tractable and transparent model organism C. elegans to identify novel
mechanisms underlying IF and longevity. Here, I show new data to suggest the transcription factor CREB and
mitochondrial dynamics are indispensable for lifespan extension by IF. This project will dissect the mechanisms
by which CREB mediates IF-longevity on the level of transcription, organelle biology and metabolism. I will
interrogate the potential role of CREB as a cell non-autonomous modulator of IF-longevity from the central
nervous system and investigate if mitochondrial dynamics lies functionally downstream of CREB to mediate IF-
longevity. The spatial and functional requirement of mitochondrial remodeling for IF-longevity will be determined
to elucidate whether CREB and mitochondrial dynamics are required in the same tissue. Two-photon excited
fluorescence of endogenous NADH and FAD levels will then be used as a non-invasive method to measure
metabolic state in vivo. I will use this technique to simultaneously extract information on mitochondrial network
morphology and how it corresponds to metabolic changes during IF and manipulation of CREB activity. Overall,
these studies will provide new mechanistic insight into IF biology, which can be harnessed to develop new
therapeutics against aging. Pallas’ position as a graduate student in Dr. William Mair’s laboratory at the Harvard
T.H. Chan School of Public Health gives her access to all the resources necessary to complete this project. As
part of the training plan, Pallas will develop her career plan, writing and communication skills through participation
in local and national/international scientific conferences, peer reviewing journal articles, and mentoring
undergraduate students. The goal is to further develop her scientific acumen in experimental design in order to
move her further toward independence as she transitions into a postdoctoral position.

Public health relevance
PROJECT NARRATIVE Intermittent fasting (IF) is a dietary intervention that promotes healthy aging independent of chronic restriction of food intake. Although the therapeutic potential of IF may be more translatable than chronic DR, the mechanisms underlying IF and longevity are understudied. This project aims to apply state-of-the-art genetic and cell biology techniques to elucidate the role of CREB as a novel regulator of IF-longevity.